Research Education Core

PROJECT SUMMARY
Research Education Core
As an essential core of the Center, the Research Education Core (REC) will build new LHS research and
learning infrastructure that strengthens institutional research training in comparative effectiveness research
(CER) and patient centered outcomes research (PCOR); enhances diversity in the LHS research workforce;
strengthens partnerships with community partners and health systems and other stakeholders; and conducts
PCOR/CER projects to improve health system operations, quality, and health outcomes. The REC will
implement a plan to enhance training, professional development, and diversity in the LHS workforce, by
recruiting a cadre of diverse LHS scientists and match them with mentors with expertise in relevant areas and
supporting them in receiving didactic and experiential learning opportunities. The REC will include the following
components:
• Supporting PCOR/CER research projects for LHS scientists relevant to AHRQ/PCORI priorities: LHS
scientists will propose PCOR/CER research projects relevant to AHRQ/PCORI priorities after they have
a good understanding of the priorities of learning health systems where they plan to conduct their
research. The REC guidance committee (PI, Co-PI, and core faculty members) will provide feedback to
LHS scientists to ensure alignment of the two sets of priorities and the professional interests of LHS
scientists.
• Mentoring LHS scientists to achieve research career training objectives: The proposed UCSD LHS
Center offers an ideal infrastructure to support mentoring, didactic, and experiential training of LHS
scientists because of the combination of University of California San Diego as a highly ranked public
university in the U.S. and learning health systems including UC San Diego Health, El Centro Regional
Medical Center, and the Family Health Centers of San Diego.
• Mentorship within academic settings: Researchers from diverse backgrounds and groups
underrepresented in science are faculty and mentors in the REC. These individuals have remarkable
research expertise and experience relevant to the proposed Center and demonstrate a rich history of
their role as LHS Science mentors.